Nanoparticle targeting within the joint for site-specific delivery of osteoarthritis therapeutics

PROJECT SUMMARY
Osteoarthritis (OA) is a leading cause of disability in the United States and is presently without a cure.
Despite advances in drug discovery and cell based therapies, disease-modifying therapies have remained
elusive. OA is a complex disease involving maladaptive remodeling throughout the joint, including cartilage
erosion, synovitis, and bone remodeling. The continuum of joint damage creates a chronic pro-inflammatory
and catabolic joint environment, which ultimately destroys the joint's anatomy and physiologic function. There
is a critical need for an OA therapy to address multiple disease mechanisms in multiple locations throughout
the joint. While numerous drugs and factors have been identified for promoting cartilage repair and blocking
various OA disease mechanisms, rapid joint clearance and poor tissue targeting limit their clinical application.
This proposal lays the foundation for a comprehensive approach to treating OA that focuses on delivering the
right drug in the right place at the right time in the joint. Specifically, this proposal aims to design drug carriers
that can simultaneously delivery chondroprotective signals to the cartilage and immunomodulatory signals to
synovial macrophages. We hypothesize that site-specific drug delivery that targets multiple disease processes
will improve cartilage protection and prevent/reduce chronic joint inflammation, synergistically slowing/stopping
OA progression. Specific Aim 1 focuses on the development of nanoparticle-based drug carriers that bind to
and penetrate cartilage tissue, enabling sustained release of the chondroprotective drug, kartogenin, within the
cartilage itself. Nanoparticle biodistribution and cartilage retention will be evaluated, as will the
chondroprotective effects of site-specific kartogenin delivery in rodent models of OA. Specific Aim 2 focuses on
the development of biocompatible particles that localize to the inflamed synovium and deliver a potent
immunomodulatory signal, CD200, to macrophages. The influence of CD200 delivery on macrophage
polarization, inflammatory cytokine production, and PTOA progression will be determined. Specific Aim 3 will
study the combination the cartilage protecting and immune cell modulating drug delivery systems, and evaluate
therapeutic effectiveness compared to each individual system alone. These studies will be performed in rodent
model of OA that simulate many of the features observed in human patients. Therapeutic efficacy will be
determined by comprehensive evaluation of structural, biochemical, and behavioral (pain and gait) metrics of
the disease. Overall, the proposed work will advance knowledge and technologies for targeted drug delivery
within the joint. Moreover, this work will also reveal new insights on the role of chondroprotection and
macrophage immunomodulation on joint structure and function. By providing site-specific localization of OA
drugs that simultaneously target multiple, synergistic pathways in the joint, we hope to overcome some of the
limitations with existing treatment paradigms and move closer towards a cure for OA.

Public health relevance
NARRATIVE Osteoarthritis (OA) is a leading cause of disability in the United States, for which there is no cure or therapy that can slow or reverse the course of the disease. Given the complex, intertwined degenerative processes occurring in the OA joint, an effective therapy may require targeting of multiple disease mechanisms in multiple locations in the joint. The goal of this proposal is to develop site-specific drug carriers that can deliver the right drug to the right place at the right time in the joint, targeting multiple disease pathways simultaneously to effectively reduce OA disease progression.